Developing pregnancy-specific dialectical behavior therapy skills to promote multigenerational mental health

PROJECT SUMMARY/ABSTRACT
Emotion dysregulation in pregnancy is an impairing transdiagnostic vulnerability factor that has critical
implications for two generations. Although mental health in pregnancy has been a focus of basic and translational
research, most studies have focused on maternal depression or anxiety, neglecting other severe clinical
disorders characterized primarily by emotion dysregulation (e.g., personality disorders; self-injurious thoughts
and behaviors). The proposed study will test the premise that targeting emotion dysregulation may have
transformational benefits for pregnant women and, importantly, may function as a prenatal intervention to affect
infant health prior to birth. This innovative R61/R33 proposal proposes a novel group skills intervention that will
address the unique emotional needs of pregnancy by applying effective elements of dialectical behavior therapy
skills—a treatment that is ideally suited for improving emotion regulation. We expect that reducing maternal
prenatal emotion dysregulation will in turn improve infant neurobehavioral and self-regulation at birth and 6
months, making this a novel preventive intervention for infants. Data from our laboratories supports the premise
that high prenatal emotion dysregulation associates with blunted maternal physiology and infant neurobehavioral
dysregulation. Unknown is whether it is possible to improve maternal and infant health with a unique, emotion-
focused intervention designed to engage two key targets: maternal emotion regulation skills or physiological
regulation via respiratory sinus arrhythmia (RSA). In the R61 phase, participants will be randomized to our newly
developed perinatal DBT skills (DBT-P) compared with an assessment only (AO) control (N=40/group) to
establish target engagement of increased emotion regulation skills or resting-state RSA. In the R33 phase,
findings will be extended by comparing DBT-P with an active control (Moms2B), an established prenatal group
health-based intervention to improve nutrition (N=50/group), to determine whether DBT-P improves newborn
and infant behavior regulation. Across both phases, women will be enrolled based upon high emotion
dysregulation scores (≥88) on the Difficulties with Emotion Regulation Scale (DERS) and outcomes will be
assessed with a pre-post, intent-to-treat design. Target engagement is defined as increases in clinician-assessed
emotion regulation skills (clinical target) or resting-state RSA (biological target). To accomplish these innovative
aims, we will use our established protocols to recruit, enroll, and retain dysregulated pregnant participants and
our existing strategies for assessing newborn neurodevelopment using the Neonatal Network Neurobehavioral
Scale (NNNS) and infant self-regulation. This study capitalizes on the talents of the investigative team, which
unites experts in maternal-infant mental health, clinical trials management, and DBT. Our study is significant
because it will result in a novel intervention targeted specifically for emotionally dysregulated pregnant women
with the innovative potential to improve infant regulation prior to birth.

Public health relevance
PROJECT NARRATIVE Emotion dysregulation is an impairing vulnerability factor related to nearly all psychological disorders that also has intergenerational implications, yet no randomized controlled trials exist for treating emotion dysregulation during pregnancy. We are developing DBT-P, an intervention for pregnant people with high emotion dysregulation to determine whether this intervention improves maternal and infant mental health. This study will provide valuable information about how to intervene and interrupt the intergenerational transmission of emotion dysregulation.